Deciphering the Mechanisms Underlying Neuroendocrine Cell Hyperplasia of Infancy

PROJECT SUMMARY
Neuroendocrine Cell Hyperplasia of Infancy (NEHI) is a rare pediatric lung disease characterized by
chronic tachypnea, low blood oxygen saturation requiring supplemental oxygen, and often failure to thrive. A
defining pathological feature of NEHI is the observed increase of pulmonary neuroendocrine cells in lung
biopsies. However, it is unknown if this increase, or other genetic or environmental factors cause the disease.
Mimicking an NKX2.1 point mutation identified in NEHI patients, we engineered the first animal model of NEHI
in mice carrying this patient mutation. Our preliminary data indicate that this model recapitulates key features
of the disease. We will use this model as an entry point to address key clinical questions associated with NEHI
pathogenesis. As there is no particular therapy for NEHI beyond supportive care, our findings may inform
specific pharmacological therapy targeting the key NEHI disease causal factors.

Public health relevance
NARRATIVE Neuroendocrine Cell Hyperplasia of Infancy (NEHI) is a rare lung disease with severe morbidities affecting respiratory function of young children. The goal of this study is to test the hypothesis that the increase in pulmonary neuroendocrine cells, a defining pathological characteristic, is responsible for the impaired gas- exchange and other symptoms of the disease. We expect that our findings will provide critical insights into how pulmonary neuroendocrine cells increase, and how they impact the pathophysiology of NEHI as well as a wide spectrum of other lung diseases associated with neuroendocrine cells.